University of Wisconsin-Madison Postbaccalaureate Research Education Program (PREP) for increasing student preparedness in STEM

PROJECT SUMMARY
The University of Wisconsin-Madison (UW) is a vibrant research institution that seeks to establish a one-year
Postbaccalaureate Research Education Program (UW-PREP) to develop skills for underrepresented minority
(URM) students to be successful in gaining leadership roles in the biomedical workforce. The goals of this
program are to prepare students to apply, matriculate, and then graduate from outstanding doctoral (Ph.D.)
programs from the UW and throughout the country. While the UW hosts a wide range of URM STEM initiatives
ranging from high school through undergraduate, graduate, postdoctoral and faculty programs, the establishment
of UW-PREP will address a gap in our programming. The mission of the UW-PREP is threefold: 1) to provide
opportunities and evidence-based platforms for participants to learn how to design and conduct impactful,
rigorous and reproducible scientific research; 2) to foster the growth of participants in areas of professional
development that promote self-awareness and advocacy, build science communication skills, and reinforce an
identity as a scientist; and 3) to advance an inclusive culture of mentoring, research integrity, and life-long
learning. The UW-PREP will be established with a primary focus on a mentored research experience in which
participants will be immersed in developing skills needed to design and conduct rigorous, ethical research. The
UW has outstanding resources and infrastructure in place to support innovative and impactful research. PREP
Research Education Activities will be designed on recent UW-developed and published Entering Research
curricula, a collection of evidence-based active learning activities. Activities will reinforce the importance of rigor
and reproducibility and foundations of responsible conduct of research that will also be inherent to their mentored
laboratory experience. They are also designed to help students devise their Individual Development Plan (IDP)
and will incorporate Professional Development activities to build STEM-specific social capital to navigate the
hidden curriculum of academic research spaces in a large research institution. Faculty advisors and benchside
mentors will participate in evidence-based Mentor Training curricula designed around six core competencies:
Align Expectations, Communicate Effectively, Assess Understanding, Address Equity and Inclusion, Foster
Independence, and Promote Professional Development. PREP Leadership and funded, diverse faculty enjoy
outstanding institutional support and coordination of evidence-based curricula to build a PREP that will help to
launch exceptionally trained and confident URM scholars into the biomedical workforce.

Public health relevance
PROJECT NARRATIVE Economic prosperity and research institution competitiveness demand diversity of the biomedical workforce and diversity in the breadth of scientific inquiry; however, there is a documented shortage of underrepresented minorities (URM) represented in science. Thus, this proposal will establish a new one-year Postbaccalaureate Research Education Proposal at UW-Madison (UW-PREP) that will fill a current gap that exists in the pipeline for increasing the number of URM individuals that are prepared to take on rigorous graduate training in the biomedical sciences. The UW-PREP uses evidence based Entering Research and Mentor Training curricula alongside a vast array of resources and dedicated faculty and staff to prepare extraordinary URM scholars towards impactful and productive careers in the biomedical workforce.